PROGNOSTIC SERIAL HEMODYNAMIC PARAMETERS IN PATIENTS WITH SEPTIC SHOCK

Serial hemodynamic parameters were performed on 48 consecutive patients with septic shock and analyzed for early prognostic patterns. It was found that a relatively low heart rate on initial evaluation or 48 hours later were good prognostic signs. A fall in heart rate or in cardiac index over the first 24 hours were also good prognostic signs, as was a normal systemic vascular resistance index after the first 24 hours. These hemodynamic parameters provide helpful information which allow attention to be focused on patients with a poor prognosis so that the mechanisms of death can be studied and therapy devised to prevent these developments.